Reconstructing the ancestral neural crest-pluripotency gene regulatory network

Project Summary
Understanding how stem cell attributes are controlled and how they evolve to generate diverse and novel cell
types is essential to understanding how mis-regulation of these processes results in stem cell-linked
pathologies. My research will focus on two key stem cell populations, pluripotent blastula stem cells and neural
crest (NC) stem cells that both arose at the base of the vertebrates. NC cells give rise to many of the hallmark
anatomical, physiological and behavioral traits of vertebrate animals—including humans—and defects in the
development of these cells is linked to a broad set of birth defects and cancers. Previous work has shown that
the gene regulatory networks (GRNs) deployed in NC cells and blastula stem cells are highly overlapping. The
overall goal of this project is to use comparative studies in three organisms that represent key nodes
in the chordate phylogeny to dissect the gene regulatory logic underlying the development and
evolution of these important stem cell populations in vertebrates. Under the mentorship of my sponsoring
scientist and career advisory board I will combine genomic and functional studies in a jawed vertebrate
(Xenopus laevis), a basal jawless vertebrate, the sea lamprey (Petromyzon marinus), and an invertebrate
chordate (Ciona intestinalis). My research will trace the developmental origins of “stemness” in vertebrates and
provide novel insights into the molecular-genetic processes controlling how stem cells arise in the embryo and
how aberrant execution of these processes leads to defects in the formation of these key stem cells that are
essential for early embryonic development. My mentored training plan during the K99 phase of my research as
a postdoctoral fellow will enable me to incorporate a new model system, Ciona, into my research program,
develop new experimental techniques, and acquire expertise in cutting-edge, single-cell “multiomic”
approaches and associated bioinformatic and computational analyses. During the R00 phase I will utilize this
new expertise to provide novel insights into the molecular, cellular, and developmental mechanisms underlying
the formation and maintenance of these stem cell populations at unprecedented single-cell resolution. My
sponsor and advisory board members are outstanding scientists and mentors whose expertise will catalyze my
transition to Principal Investigator of my own laboratory. My long-term career goal is to establish a productive
independent research program that uses multiple model systems to make important discoveries about the
gene regulatory control of stem cell attributes during development and evolution, and how mis-regulation of
these processes leads to congenital defects and cancers.

Public health relevance
Project Narrative How do stem cells produce diverse and novel cell types, and what are the gene regulatory mechanisms that underly these fundamental processes in vertebrates? My proposed research will address these questions through comparative studies of neural crest (NC) stem cells and the pluripotent blastula stem cells from which they are derived in three evolutionarily informative model systems. Because NC cells give rise to many of the hallmark anatomical, physiological, and behavioral traits of vertebrate animals—including humans—and defects in the development of these stem cells is linked to birth defects (neurocristopathies) and cancers, my research will reveal fundamental new roles of NC and blastula stem cells in development, disease, and evolution.